EXCEL Single Topic Symposium: EGID Xcelerating Care, Research, and Innovation in an Evolving Landscape

Project Summary/Abstract:
Since the last North American Society for Pediatric Gastroenterology and Nutrition (NASPGHAN) eosinophilic
gastrointestinal disorders (EGIDs) single-topic symposium over 16 years ago, EGIDs have emerged as a
leading cause of GI inflammatory disorders with an increasing prevalence of over 200,000 children and adults
in the United States. There have been over 40 clinical trials published during that time, including the first FDA
approved eosinophilic esophagitis biologic therapy, innovations such as unsedated endoscopy and esophageal
function testing, and a more advanced understanding of EGID pathophysiology. These advances have
resulted in an urgent unmet need for an updated targeted scientific review conference on pediatric
EGIDs.
The EXCEL Single Topic Symposium: EGID Xcelerating Care, Research and Innovation in an Evolving
Landscape one-day symposium will be held the day prior to the NASPGHAN Annual Meeting at the Diplomat
Hotel in Hollywood, FL on November 6, 2024. Our objective is to bring together a multidisciplinary audience of
physicians, researchers, advanced practice providers, dietitians, allergists, pathologists, and patients and
patient advocacy groups to share their unique perspectives and expertise with a broad anticipated audience of
500-800 participants. Topics will include cutting edge information on basic, translational, and clinical trial
research, as well as innovations in EGID diagnostics, monitoring, and treatment options in the pediatric
population.
This symposium will place particular emphasis on the recruitment and inclusion of young investigators to
connect the next generation of talent with mentorship and collaborations and give voice to their top priorities for
future research in the field of pediatric EGIDs. To this end, small group mentoring and career planning
sessions, as well as multiple events in our SPARK! initiative (a Supportive Platform for Advancing Research
and Knowledge) are specifically targeted to bring together participants across the career spectrum. Junior
investigator abstracts will be solicited and highlighted in oral and poster presentation settings with emphasis on
discussion, mentorship, and collaboration. Early Career Travel Awards will be provided to qualified trainees
(graduate students, postdoctoral fellows) and junior faculty (<5 years from start of first faculty position) to help
defer the cost of travel, lodging and registration. NASPGHAN, the NASPGHAN Diversity Committee, and the
EXCEL STS planning committee have collaborated to create a program that promotes diversity throughout our
organizing committee, proposed speakers, moderators, and panel discussants. We will communicate all
EXCEL STS findings to the wider EGID community with published abstracts and conference proceedings.

Public health relevance
Narrative Since the first and only North American Society of Pediatric Gastroenterology, Hepatology and Nutrition (NASPGHAN) eosinophilic gastrointestinal diseases (EGIDs) single topic symposium was over 16 years ago, the major goal of the 2024 NASPGHAN “EXCEL Single Topic Symposium: EGID Xcelerating Care, Research and Innovation in an Evolving Landscape” is to bring together diverse, multidisciplinary, national and international experts, researchers, advanced practice providers, dietitians, patients, and families to share and discuss novel EGID research and clinical care. The symposium will be held on November 6th, 2024 at the Diplomat Hotel in Hollywood, Florida which will provide supportive and inclusive training environment to engage junior investigators and under-represented groups to exchange the most current science, interact with established leaders in the field, and influence future directions of pediatric EGID research. This symposium will enhance public health by increasing diversity and knowledge in the field, and it will focus the attention of the next generation of investigators and healthcare providers on the needs of our estimated 41,000 pediatric EGID patients in the United States.